A Multimethod Assessment of the Clinical, Economic & Social Impact of the Rejection of Federal HIV Prevention Funds in Tennessee

Project Summary Abstract
HIV remains a major public health concern in the United States (US) with a disproportionate burden of
disease in the US South, including Tennessee. The proportion of people with HIV (PWH) in Tennessee in 2019
who knew their HIV status (85%), were linked to care (61%), were retained in clinical care (59%), and had
suppressed viral loads (65%), were well below US Ending the HIV epidemic goals (90%). People residing in
rural areas, men who have sex with men (MSM), and Black and Hispanic people continue to bear the highest
burden of HIV disease and have poor HIV continuum of care outcomes in Tennessee. These statewide
disparities are more starkly mirrored in Memphis/Shelby County, a Phase 1 EHE Priority Jurisdiction and a
Metropolitan Statistical Area (MSA) that ranks 3rd in the US for HIV incidence. In this public health context, the
state of Tennessee has decided to reject ~$9 million dollars in federal funding for HIV testing and prevention
effective June 1, 2023. The public health impact of rejecting federal funding for community-based HIV services
is likely to be profound given the years of experience, deep institutional knowledge, and community trust these
organizations have built. Further, the state has enunciated new “priority populations” responsible for only a
handful of HIV cases in Tennessee in the past decade (i.e., first responders, victims of human trafficking, and
pregnant women and children), in addition to the key populations known to have a high risk of HIV and high
need for these services (i.e., rural residents, MSM, and Black and Hispanic people). These changes represent
an urgent quasi-experimental event that requires evaluation to assess changes in HIV prevention and care
outcomes related to this policy shift. Thus, our overarching goal is to provide a near-real-time evaluation of
whether and how policy changes to funding HIV testing and prevention in Tennessee will affect HIV outcomes,
particularly among populations highly vulnerable to HIV. We are uniquely positioned to perform the work in this
proposal as our study team has complementary expertise in Tennessee clinical HIV testing and prevention,
HIV modeling, health policy analysis, and qualitative research to ensure the timely initiation of the project with
minimum delay. Our findings will provide clear, rigorous evidence in a near-real-time evaluation of whether and
how policy changes to funding HIV prevention and care in Tennessee affect HIV outcomes, particularly among
populations highly vulnerable to HIV. Although focused on Tennessee, results are relevant to broader policy
discussions around the direction of federal funding to community-based organizations for public health
programs already emerging across the US South. Importantly, our work will support Tennessee communities in
reaching their Ending the HIV Epidemic (EHE) goals through the leveraging of our unique academic and
community-based partnerships.

Public health relevance
Project Narrative The public health impact of rejecting federal funding for community-based HIV services in Tennessee is likely to be profound, with the potential to widen disparities in HIV testing and prevention services for racial, sexual/gender, and rural residential minorities. Thus, our overarching goal is to provide a near-real-time evaluation of whether and how policy changes to funding HIV testing and prevention in Tennessee will affect HIV outcomes, particularly among populations highly vulnerable to HIV. Although focused on Tennessee, results are relevant to broader policy discussions around the direction of federal funding to community-based organizations for public health programs already emerging across the US South.